Molecular Regulation of Atherosclerosis Regression - Renewal

ABSTRACT
Coronary plaques begin their progression in childhood, making their reversal an important clinical goal in
adulthood. The understanding of mechanisms underlying atherosclerosis regression has been understudied
compared to plaque progression. Atherosclerosis represents a failure to resolve the maladaptive immune
response that maintains plaque growth through the accumulation of pro-inflammatory immune cells.
The central inflammatory cell in the plaque is the macrophage (Mø) in the activated state. We previously
showed that plaque regression in mouse models is characterized by the enrichment of Møs in the inflammation
resolving state (which we will refer to as proR-Møs). We have recently shown that these proR-Møs are required
for regression. We also have observed in regressing plaques increased numbers of inflammation dampening
CD4+ regulatory T cells (Tregs), which prevent the expansion of effector T cells and support proR-Mø functions.
Furthermore, our results point to Wnt-signaling and chemokine receptor CCR7 as key pathways associated with
a pro-resolving environment. We hypothesize that all of these factors play important roles in the reprogramming
of the plaque inflammatory milieu to enable inflammation tissue repair in the artery wall and thereby promote
atherosclerosis regression.
The development of novel therapies for atherosclerosis must also take into account “real world” clinical
issues. Accumulating data now show that the majority of treated patients intermittently adhere to statins, which
increases their CAD risk. We hypothesize that epigenetic reprogramming of macrophages and their precursors
by IH through trained immunity mediates these adverse effects on atherosclerosis, further hindering inflammation
resolution and rendering plaques susceptible to accelerated disease and refractory to regression. We have
developed the following specific aims to investigate the factors and pathways that drive or hinder
inflammation resolution and plaque remodeling during atherosclerosis regression:
Aim 1: To study the regulation of the inflammation-resolving properties of plaque Møs by Wnt-signaling.
Aim 2: To determine the role of CCR7 in the resolution of atherosclerotic inflammation and plaque
regression.
Aim 3: To establish the mechanistic basis for increased coronary artery disease risk in patients with
intermittent statin adherence.
In summary, this proposal represents an exciting opportunity to continue to combine our collective expertises to
address crucial gaps in our knowledge of the resolution of inflammation in atherosclerosis.

Public health relevance
PROJECT NARRATIVE Atherosclerosis is a disease in which plaques with inflammatory cells accumulate in arteries. People at risk for heart attacks only partially benefit from current treatments to prevent the clinical events these plaques cause. To effectively reverse plaques, their inflammation must resolve, and ways to achieve this are the focus of this proposal.